Blood Pressure Variability and Ischemic Stroke Outcome (BP-VISO)

PROJECT SUMMARY/ABSTRACT
Stroke affects 800,000 Americans every year and remains a leading cause of long-term disability. Increased
blood pressure variability (BPV) has consistently been associated with two to three times higher risk of disability
or mortality after acute ischemic stroke (AIS) in retrospective analyses, independent of mean blood pressure.
Our central hypothesis is that increased BPV is harmful after AIS and warrants reduction. However, prior BPV
research in AIS patients has been retrospective and limited by non-standardized BP measurement and,
therefore, BPV is not mentioned in current stroke guidelines. To address the limitations of prior BPV research,
determine mechanisms of BPV's deleterious effect, and identify potentially effective methods to reduce BPV, the
proposed study will: 1) prospectively validate that “short-term” and “long-term” BPV after AIS onset is associated
with functional outcome and define the effect size of different levels of BPV, 2) utilize portable MRI to confirm
that final infarct volume, infarct growth and hemorrhagic transformation between baseline (measured within 12
hours of hospital arrival) and 72 hours are mechanistically related to BPV, and 3) utilize bedside pupillometry to
determine how the autonomic nervous system contributes to BPV after AIS and evaluate the class effect of
antihypertensive medications on BPV. To achieve these goals, we will enroll 150 patients who have anterior
circulation stroke and a baseline NIH Stroke Scale ≥6 within 12 hours of AIS onset at three study sites. With
completion of the Aims, we will define the outcome for a future trial (disability at 90 days vs. infarct volume or HT
vs. post-stroke cognitive impairment at 12 months vs. composites), the effect size of BPV on individual outcomes
and composites, the duration for lowering BPV (24-72 hours vs. weeks or months), and potential interventions
to reduce BPV. Pharmacologic BPV reduction would be an inexpensive and widely available intervention, able
to be administered in a range of healthcare settings. By completing the proposed Aims, we will be ideally
positioned to test accessible targeted interventions to diminish the morbidity and mortality of AIS.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health because stroke is a leading cause of long-term disability and death in the United States and better treatments are needed. Building on our preliminary research showing that blood pressure variability after stroke may be harmful, in this study we will prove this relationship to be true and define critical elements for a future trial dedicated to lowering blood pressure variability.